Admin-Core

Project Summary/Abstract The Vasculitis Clinical Research Consortium (VCRC) is a founding member of the Rare Diseases Clinical Research Network (RDCRN). The VCRC is the major clinical research infrastructure dedicated to the study of vasculitis. The VCRC was established in 2003 and has grown to include up to 90 academic medical centers worldwide in conducting investigator-initiated clinical and translational research. The VCRC conducts observational cohort studies, biomarker development, studies of genetics and genomics, clinical outcomes research, studies using an online research resources, including a patient registry, pilot clinical projects, and multicentered, randomized clinical trials. Core components of the VCRC include the VCRC Coordinating Center, the VCRC Longitudinal Study, the VCRC Clinical Trials Program, the VCRC Pilot/Feasibility Core, the VCRC Clinical Data, Biospecimen, and Tissue Repositories and VCRC Laboratory, VCRC Online Research Resources [Vasculitis Patient-Powered Research Network, the VCRC Patient Contact Registry, VCRC Website], the VCRC Steering Committee, the VCRC-NIH Data and Safety Monitoring Board, all coordinated through the VCRC Administrative Core. The VCRC also hosts a public website providing information to patients about vasculitis and our research programs. The VCRC-VF Fellowship provides support for mentored training focused on clinical care and research in vasculitis. The VCRC Administrative Core provides support to the overall research infrastructure of the Consortium, including core administrative functions required to effectively and efficiently direct the operations of the VCRC clinical research infrastructure. The VCRC Administrative Core personnel includes the Principal Investigator (Administrative Director), the Administrative Coordinator, the VCRC Laboratory Technician, the Financial Manager, the Patient Engagement Director, the Clinical Team Liaison, and Directors of the Clinical Trials Program, Pilot/Feasibility Core, and Career Enhancement Core. Another important role of the VCRC Administrative Core is to maintain excellent intra-Consortium communication. The administrative structure of the Consortium has grown and evolved to most effectively and efficiently serve the needs of the group, and will continue to do so over the next 5 years to ensure that the Consortium runs smoothly, effectively, and productively.